Understanding the Role of EIF4A2 in Neurodevelopment

PROJECT SUMMARY/ ABSTRACT
Neurodevelopmental disorders (NDD) are common, affecting 3% of the global population with emerging
data suggesting that many are attributable to a genetic etiology. In the DEAD-box family of RNA Helicases,
18% of the genes have been shown to be important for neurodevelopment with pathogenic variants leading to
a range of NDD. Through the proposed NIH Mentored Clinical Scientist Career Development (K08) Award, the
role of the DEAD-Box encoding gene, EIF4A2, in interneuron development will be evaluated
Pathogenic variants in EIF4A2 lead to a NDD characterized by intellectual disability, epilepsy,
hypotonia and structural changes in the developing brain. Modelling of EIF4A2 missense variants in Drosophila
demonstrates that both loss- and gain-of-EIF4A2-function alter neurodevelopment. However, the mechanisms
by which EIF4A2 loss- or gain-of-function alter brain development and the timing of these events have yet to
be determined. Preliminary studies utilizing acute CRISPR gene editing of zebrafish demonstrate that loss of
EIF4A2 leads to a reduction in interneuron number, suggesting reduced GABA interneuron generation,
impaired differentiation and/or alterations in migration may have occurred.
In this K08 proposal, the role of EIF4A2 in interneuron development and the impact of loss and gain of
function on this process will be studied in zebrafish. Zebrafish are an optimal model system since they permit
rapid genetic editing, are excellent for live imaging, and have well conserved stages of neurodevelopment. The
following 5 groups will be compared: wild type controls (WT), eif4a2 +/-, eif4a2 -/- , WT with overexpressed
EIF4A2 mRNA, and eif4a2 -/- with EIF4A2 mRNA rescue. In Aim 1, EIF4A2 loss- and gain-of-function
zebrafish models will be generated and their phenotypes characterized. In Aim 2, using these models, the role
of EIF4A2 in interneuron progenitor cell generation and differentiation will be examined. In Aim 3, the impact of
loss- and gain-of EIF4A2 function on GABA interneuron migration will be assessed. By understanding
EIF4A2’s role in each aspect of interneuron development, targets of opportunity for future investigation will be
identified for both EIF4A2-associated NDD and more common conditions involving interneuron dysfunction.
International experts in neurobiology, zebrafish, genetics, and neurogenetics will provide mentorship for
this proposed Career Development Award. The primary mentor will be Ann Poduri, MD, MPH. The Scientific
Advisory Committee will be composed of Kevin Staley, MD, David Sweetser, MD, PhD, Gordon Fishell, PhD,
and Pankaj Agrawal, MD, MMSc. They will provide guidance for both the short-term goal of understanding the
role that EIF4A2 plays in neurodevelopment and the long-term goal of improving neurodevelopmental
outcomes of infants and children with both rare and common causes of NDD.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental disorders are common, affecting 3% of the global population; these conditions include global developmental delay/intellectual disability, epilepsy, and autism spectrum disorder and are collectively associated with significant healthcare costs for the many children and families affected. Interneuronopathies are becoming more widely recognized as an important cause of neurodevelopmental disorders, with Fragile X and autism both associated with interneuron impairment. This K08 proposal will elucidate both the mechanism and the timeline during which EIF4A2, a DEAD-box encoding gene and novel regulator of interneurons, alters interneuron development, providing direction for future investigations of interneuron-targeted therapeutics.